Decoding Age Differences in Emotional Well-being and Positivity through Everyday Natural Conversations

Project Summary
With age, individuals are often faced with more negative life events, such as declining health or the death of a
loved one. But, older adults tend to report better emotional well-being than younger adults (e.g., more positive
affect, greater happiness), and older adults show a greater attention to and appreciation for positive
information relative to negative information compared to younger adults. These differences suggest that basic
cognitive and emotional processes may change in older age, becoming more positive in general. However,
most of the existing evidence regarding these age differences is based on self-report measures and lab-based
tasks. Thus, it is uncertain whether these age differences are observable in the “real-world.” Furthermore, the
reasons for age differences in emotional well-being or appreciation for positive information are unclear. The
proposed project is a feasibility study in which an innovative behavioral assessment will be utilized to test
whether age differences in emotional well-being and appreciation of positive information can be captured in
natural, everyday social environments. Furthermore, a behavioral assessment of present moment time
perspective will be tested as a possible mechanism underlying age differences in emotional well-being and
appreciation for positive information. An adult life-span sample (N =120; 40 young adults, 40 middle-aged
adults, and 40 older adults) will be recruited to wear a digital recording device for four days (two week days
and two weekend days), recording for at least eight consecutive hours each day. Audio recordings will then be
coded for emotional well-being, positivity versus negativity, and time perspective. Older age is expected to be
related to better emotional well-being. That is, older adults' conversations are expected to contain more
behavioral indicators of positive mood (e.g., laughter, calmness). Older age is also expected to be associated
with greater emphasis on positive than negative information, as indexed by a greater proportion of positive
conversation content than negative content. Finally, older age is expected to be associated with greater focus
on present time, rather than past or future, as indexed by conversation content and verb tense. Differential time
perspective may account for age differences in emotional well-being and positivity. The proposed project will
clarify whether age differences in emotional well-being and appreciation for positive information are
phenomena observable in everyday life and will potentially elucidate an underlying mechanism – present time
perspective. The proposed feasibility study will provide a novel, ecologically valid assessment tool of emotional
well-being, positivity, and time perspective in an adult lifespan sample and will serve as the foundation for
future collaboration between the team members and research on healthy aging. In particular, findings from this
study may inform interventions to promote emotional well-being and subsequent mental and physical health in
older adults, as well as people of all ages.

Public health relevance
Project Narrative By 2030, nearly 20% of the US population is expected to be 65 years of age or older, and by 2050, 88.5 million US citizens are projected to be over 64 years old. Given the rate at which the national population is aging, it is important to understand how cognitive and emotional processes change across the lifespan and identify processes associated with healthy aging. Such information can inform interventions to promote emotional well-being and subsequent mental and physical health in older adults, as well as people of all ages.